Cancer Navigation Platform (Cancer Moonshot)

Locus Health, in this Phase II effort, will further develop and demonstrate the utility and commercial viability of its
scalable, HIPAA-compliant Cancer Navigation Platform. The long-term goals of this Platform are to improve cancer
patient outcomes and the efficiency and quality of patient navigation. Building on Phase I results, the project team will
further develop the Platform’s patient engagement and navigation capabilities that promote targeted patient education,
communication with patients and among the care team, care coordination including effective two-way integration with
the EMR, patient scheduling, and resource access and referrals, with particular emphasis placed on support for Social
Determinants of Health. The project will test patient engagement, adherence, navigator efficiency, and key patient
outcomes by initiating pilot implementations at two sites, Inova Schar Cancer Institute and the University of Virginia
Cancer Center. At the end of these pilots, parallel usability studies will be conducted at both sites to test key aspects of
the patient, navigator, and integration capabilities to provide specific feedback for a further development cycle. In
addition to commercializing the Platform at the two sites, the team expects to also secure 2-3 additional commercial
commitments at leading Cancer Centers/Health Systems. (Funded by Cancer Moonshot)